Visualizing of Immune Responses to Toxoplasma Gondii

DESCRIPTION (provided by applicant): Toxoplasma gondii is an intracellular protozoan parasite that is the causative agent of Toxoplasmosis. Toxoplasma infection in mice provides an excellent experimental model for understanding food borne infections and infections of the brain. The overall goal of this project to gain a deeper understanding of how the mammalian immune system responds to Toxoplasma infection by tracking parasites and immune cells in vivo. Our experimental approach makes extensive use of 2-photon microscopy to visualize the dynamics of parasite and immune cell interaction in living tissues. In the previous funding period, we have assembled the tools to visualize and quantitate interactions between parasites and T cells and other cells of the immune system, and have begun to address the fundamental question of where, when, and how parasites and immune cells interact in vivo. Our initial studies have provided a framework for further exploration and have led to a number of testable hypotheses about the role of T cell-parasite interactions during infection. In the current application, we propose experiments designed to test these hypotheses, and to continue building a more complete picture of the cellular events during Toxoplasma infection. Specifically we will examine early parasite spread and host immune response after oral infection (Aim 1) and examine the regulation of T cell response during chronic infection in the brain (Aim 2). PUBLIC HEALTH RELEVANCE: Toxoplasma gondii is a parasite that causes birth defects or brain infection in immunocompromised adults. We are using a mouse infection model and advanced microscopy methods to gain a better understanding of how the immune system protects against the parasite and how the parasite attempts to evade the immune system. Because Toxoplasma is a food borne pathogen and can lead to intestinal pathology, these studies have relevance for the development of mucosal vaccines and the treatment and prevention of other food borne pathogens, and the treatment of inflammatory bowel diseases, as well as infections of the brain.

Public health relevance
Toxoplasma gondii is a parasite that causes birth defects or brain infection in immunocompromised adults. We are using a mouse infection model and advanced microscopy methods to gain a better understanding of how the immune system protects against the parasite and how the parasite attempts to evade the immune system. Because Toxoplasma is a food borne pathogen and can lead to intesinal pathology, these studies have relevance for the development of mucosal vaccines and the treatment and prevention of other food borne pathogens, and the treatment of inflamatory bowel diseases, as well as infections of the brain.